ABCD-USA Consortium: Data Analysis, Informatics and Resource Center

Project Summary/Abstract
In its initial funding period, the ABCD consortium used a rigorous epidemiological approach to
recruit a diverse sample of 11,878 9-10-year-olds through our 21 research sites, of which 2136
are twins or triplets. ABCD has created a comprehensive yet efficient protocol for participating
youth and parents, using standardized and state-of-the-art methods for neuroimaging,
biospecimens, and assessments of substance use, mental and physical health, neurocognition,
culture, and environment, using a fully digital platform and making use of mobile technologies.
We ensure cohesion and standardization by having employed a recruitment strategy designed by
a professional survey company (experience with Monitoring the Future); standardized
environmental, neurocognitive and mental health assessments, MRI assessments with all
scanners using harmonized Human Connectome Project procedures, and computerized data
collection with real-time quality control. Developmentally tailored assessments will have stable
sensitivity and construct validity across the childhood and adolescent developmental period. They
minimize participant burden, yet capture even subtle changes over time in substance use, mental
health, neurocognition, development, and environment, and we employ novel state-of-the-art
bioassays and passive data collection from mobile devices. A detailed retention plan builds on
the experience and success of our investigators. This application describes the ABCD Data
Analysis, Informatics and Resource Center (DAIRC), which will: maintain and update the
harmonized MRI acquisition protocol, compatible with all major scanner platforms, taking
advantage of recent technological advances in structural and functional MRI; perform rigorous
quality control and quantitative calibration procedures to ensure accuracy and comparability of
derived imaging measures across scanners and across time; implement advanced computational
analysis workflows for all imaging data; implement reliable data entry, quality control, and
monitoring tools for the substance use questionnaire, neurocognitive assessments, bioassay-
derived measures, and mobile technologies assessment data; implement the state-of-the-art
statistical analysis tools and procedures needed to integrate information across measures and
modalities; continue development of infrastructure and procedures for public sharing of raw and
derived data and associated tools and computational workflows; and enable interactive data
exploration and analytics through a web-based Portal.

Public health relevance
PROJECT NARRATIVE The ABCD Consortium will use multimodal brain imaging, cognitive and clinical assessments, bioassays, mobile monitoring, and careful assessment of substance use, environment, psychopathological symptoms, and social functioning in 11,878 adolescents followed over 10 years to determine the effects of substance use on adolescent brain and cognitive development. Our ABCD Data Analysis, Informatics and Resource Center (DAIRC) will maintain and update harmonized MRI protocols across sites and scanners, perform quality control of raw and derived data, and implement the informatics and computational infrastructure needed for the overall project.